Admin Core

Project Summary / Abstract: Administrative Core
The Roybal Center Administrative Core will provide scientific leadership, organizational management and
governance, financial oversight, systems for monitoring progress and compliance, and infrastructure to
promote transdisciplinary interaction, collaboration, and synergy among center components. The
Administrative Core will manage the Roybal Center's overall mission and annual goals, support the Roybal
Center Behavioral Intervention Development (BID) Core, project science, and internal and external
communication. To that end, the Administrative Core's function can be summarized into three specific aims.
Aim 1. Maintain the Center's strategic vision. The Administrative Core will plan, coordinate, review and
manage the Center's activities. These activities will be summarized and communicated by the Administrative
Core through the Roybal Center's website. Furthermore, the Administrative Core will manage an External
Advisory Committee that oversees the functioning of the Center and assists the PIs in making the scientific and
administrative decisions related to the Center, including the allocation of funds for new research studies and
clinical trials. Aim 2. Oversee BID projects. The Administrative Core will generate annual progress reports for
the NIA and work with the Roybal Coordinating Center to facilitate meetings and dissemination of knowledge.
In addition, the Administrative Core will serve to help develop and identify new projects and submit new project
proposals to the NIA for approval. Aim 3. Facilitate collaborative networks. The Administrative Core will
encourage and facilitate the development of strategic collaborative networks among researchers, commercial
interests, community interests, program design interests, and governmental entities to support translation
intervention development activities. The Administrative Core, led by Dr. Gazzaley who is a well-established
researcher, will draw on his extensive experience administering large, complex, collaborative, transdisciplinary
grants. Dr. Gazzaley's role as the Executive Director of UCSF Neuroscape is well-aligned with this proposal,
as he is already managing the development, validation, and dissemination of computer-based behavioral
interventions that involve multisite collaboration across similar activities as proposed here. The UCSF teams at
Neuroscape, including the Administrative Core Co-Investigators, also have experience, as demonstrated by
pioneering published research studies, in assembling and managing large teams of developers, programmers,
data scientists, data managers, post-doctoral fellows, and research coordinators to complete projects as
proposed here.